Molecular Mechanisms of Glaucoma

SUMMARY
Glaucoma is a group of optic neuropathies characterized by slow, progressive loss of retinal ganglion cells
(RGCs), optic nerve degeneration and as a consequence, vision loss. It has been estimated that more than 70
million people are currently affected by glaucoma with approximately 10% being bilaterally blind, making it the
leading cause of irreversible blindness in the world. Several glaucoma categories exist, but in United States,
most of the cases are primary open-angle glaucoma (POAG), a variant particularly prevalent amongst African
Americans. POAG is recognized as a complex disease in which multiple genetic and environmental factors
interact. The two leading risk factors, increase intraocular pressure (IOP) and age are related to the extent and
rate of RGC loss. Recent advances in genomics have allowed researchers to describe genetic association
between the risk of glaucoma and specific genomic loci. Nevertheless, despite years of research, the molecular
basis of glaucoma is poorly understood and the factors contributing to its progression have not been fully
characterized. In our recent work, we have used a mouse model to study the molecular impact of Six6 risk
variant in development of glaucoma and in RGC death. We observed that upon increased IOP, expression of
Six6 increases and directly regulates the expression of p16Ink4a, leading to enhanced senescence in RGCs
and most likely directly causing RGC death. The gene encoding p16INK4a, CDKN2A, lies within the tumor
suppressor locus on human chromosome 9p21. This locus has been independently identified by several groups
to have the highest association with POAG in different population samples. Gene regulation within the 9p21
locus has been extensively studied in many laboratories; however, a molecular analysis has never been
performed specifically in relation to glaucoma. Mouse Six6 harbors His at position 141 and therefore is ideal to
investigate the molecular role of this variant in glaucoma. However, due to the lack of non-risk variant in mouse
strains, it is not possible to study the contribution of both variants on RGC development and degeneration in a
mouse model. Here, we propose to use CRISPR/Cas9 technology to engineer mice harboring human non-risk
variant of SIX6 to study the impact of each variant in pathogenesis of glaucoma. We will use state-of-the art
molecular and cellular technologies to study retinal development and RGC degeneration upon elevated
intraocular pressure as a function of the particular variant of SIX6. In addition, we will investigate the molecular
mechanisms of p16Ink4a upregulation in the etiology of the disease using transcriptomic and epigenomic
approaches, and we will propose the methodology to downregulate its expression in the eye. The proposed
combination of approaches will move forward the general understanding of the etiology of glaucoma and provide
the molecular basis for development of novel, personalized, therapeutic strategies to improve the quality of life
for glaucoma patients.

Public health relevance
PROJECT NARRATIVE Primary open angle glaucoma (POAG) is the most frequent form of glaucoma in the United States and a leading cause of irreversible blindness and visual impairment worldwide. The molecular mechanisms of RGC death in glaucoma are still not well understood. The proposed combination of molecular and cellular approaches will move forward the general understanding of the etiology of glaucoma and provide the molecular basis for development of novel personalized therapeutic strategies to improve the quality of life for glaucoma patients.